Administrative Core

ABSTRACT (ADMINISTRATIVE CORE)
The mission of the proposed Johns Hopkins Center for Community Health: Addressing Regional Maryland
Environmental Determinants of Disease (CHARMED) is to provide a scientific and administrative infrastructure
that facilitates the translation of fundamental environmental health research to knowledge and then to action to
address the environmental health concerns of communities in the Maryland region. The Administrative Core
(AC), which will be led by two seasoned investigators, Marsha Wills-Karp PhD (Anna M. Baetjer Professor of
Environmental Health Sciences, Chair of the Department of Environmental Health and Engineering, EHE) and
Gurumurthy Ramachandran, PhD (Professor of Environmental Health and Engineering, Director of the Johns
Hopkins Education and Research Center for Occupational Safety and Health), will ensure that the strategic
mission of CHARMED is achieved. To this end, the AC will guide and support the formation and activities of the
four Thematic Research Groups (TRGs): (a) Cardiorespiratory Health and Airborne Contaminants; (b) Chemical
Mixtures, Emerging Contaminants and Health; (c) Neurological Health; and (d) Community, Social, and
Environmental Determinants of Health. Investigators in these thematic areas are encouraged to conduct
translational research that addresses environmental challenges of residents of the Maryland region leading to
mitigation and prevention strategies to improve the health of communities in the region and beyond. The AC will
promote the use of the Integrated Health Sciences Facility Core (IHSFC), and Exposure Characterization and
Modeling Core (ECMC), to address the environmental health concerns identified by the Community Engagement
Core (CEC). To foster collaborations between Center members, community members, and/or the broader
Maryland academic community, the AC will oversee programmatic activities such as seminars, workshops, and
symposia. The Director/Deputy Director will ensure open communication among the Cores and members,
provide fiscal oversight, and provide stewardship of resources to maximize member productivity. Guidance in
decision making processes will be provided by four committees, the Executive Committee (EC), the Internal
Advisory Committee (IAC), the University Leadership Council (ULC), and the External Advisory Committee
(EAC). A central aim of CHARMED is to cultivate the careers of Early-Stage and Mid-Career Investigators in
order to establish them as the next generation of environmental health scientists focused on community-engaged
research. The ESI Career Mentoring Program is designed to provide a transformative experience to ensure that
our ESI will be equipped with the tools, resources (pilot projects) and skills required to be successful
environmental scientists. The AC will also build environmental health (EH) research capacity by bringing
established investigators into CHARMED who are new to the field of environmental health. Through these
collective activities, the AC is responsive to the NIEHS strategic plan, which stresses stewardship of resources
and building the environmental health sciences professional pipeline.